Open science platform for cancer dependency prediction and analysis using deep learning and large language models

Summary/Abstract
Cancer dependencies—genes essential for the survival and proliferation of cancer cells—represent critical
vulnerabilities that could be leveraged to develop transformative cancer treatments. Advances in machine
learning and the availability of large-scale datasets, such as the Cancer Dependency Map (DepMap), have
revolutionized the study and prediction of these dependencies; however, significant barriers remain. Biomedical
researchers often lack the computational expertise to fully leverage these resources, while computational
scientists face challenges integrating diverse datasets and ensuring reproducibility. These obstacles hinder open
science efforts and limit the broader impact of cancer dependency research. This proposal responds directly to
RFA-OD-24-010, “Building Sustainable Software Tools for Open Science,” by addressing these critical barriers
through innovative and accessible solutions. Our central hypothesis is that user-centered platforms integrating
advanced computational models with open science principles will empower researchers to identify and study
cancer dependencies, driving innovation in precision oncology. To address this, our overarching objective is to
develop two complementary tools that lower barriers for biomedical and computational researchers and enable
collaborative advancements in cancer dependency research. Aim 1 focuses on developing an intuitive, web-
based tool that enables biomedical researchers to predict and interpret cancer dependencies without requiring
advanced computational skills. Featuring a user-friendly interface and guided by a large language model-
powered assistant, this tool will provide a seamless experience for data upload, dependency prediction, and
result interpretation. Aim 2 will develop a scalable and modular computational pipeline to support computational
scientists in refining and building new prediction models for cancer dependency while integrating diverse
datasets. Built on a flexible and reproducible framework, the pipeline will allow customization of workflows to
meet specific research needs and support deployment across diverse computational environments. Both tools
adhere to the FAIR principles (Findability, Accessibility, Interoperability, and Reusability) to ensure broad
adoption and long-term sustainability. By fostering open science practices, including open-source development,
comprehensive documentation, and community engagement, our study will bridge critical gaps and promote
collaboration across cancer research and computational biology communities. This project is led by a
collaborative investigator team with extensive expertise and experience in cancer dependency research, artificial
intelligence, bioinformatics tool development, and community engagement and collaboration. Together, these
resources will empower biomedical researchers to perform sophisticated analyses and enable computational
scientists to refine innovative models. We expect this study to accelerate therapeutic target discovery and
advance precision oncology. By addressing key accessibility and scalability challenges, this proposal aligns
closely with the NIH’s Strategic Plan for Data Science and will catalyze transformative progress in cancer biology.

Public health relevance
Narrative This project aims to develop innovative tools to help researchers explore the genetic vulnerabilities of cancer cells. By making advanced computational methods accessible to all cancer researchers, regardless of their technical expertise, it will accelerate discoveries in cancer biology and assist in identifying potential drug targets. In the long term, these tools will support the development of more effective therapies and improve outcomes for patients.